The impact of HIV on accelerated aging in the female genital tract: a pilot trial of topical estradiol to improve the vaginal microbiome and symptoms of vaginal atrophy in menopausal women with HIV

HIV is associated with accelerated and/or accentuated aging, which may be mediated by chronic inflammation,
immune senescence, and/or long-term antiretroviral therapy. This translates to earlier incidence and increased
prevalence of aging-related conditions including cardiovascular, neurocognitive and bone disease. Accelerated
aging may also manifest as earlier and more significant changes in the female genital tract (FGT) mucosal
environment, which may increase risk or severity of vaginal atrophy, urinary tract and other infections.
However, the effects of HIV on FGT aging have received scant attention. Aging-associated changes in the
FGT include dysbiosis of the vaginal microbiome (characterized by a predominance of diverse anaerobes and
a decrease in acid-producing lactobacilli), increased inflammation, and disruption of epithelial integrity.
Menopausal women living with HIV (WLWH) are more likely to develop symptoms at an earlier age than HIV-
seronegative (HIV-) women. Further, our data suggests that dysbiosis occurs earlier in WLWH and is more
pronounced in older compared to younger WLWH suggesting that dysbiosis may be impacted by both HIV
infection and age. Although the precise mechanisms by which dysbiosis is linked to inflammation are unclear,
coating of bacteria with antibodies may be a key factor. We will utilize a novel technique to measure the
microbiome, IgSeq, which combines flow cytometry-based bacterial cell sorting and 16S rRNA sequencing to
characterize immunoglobulin (Ig) coating of bacteria in the FGT with the hypothesis that Ig coating of bacteria
may be protective and reduced in the setting of HIV and dysbiosis. To determine if HIV is associated with
earlier and more significant age-associated changes in the FGT, we will conduct a cross-sectional study in 50
HIV+ and 50 HIV- menopausal women to compare changes in the vaginal microbiome and mucosal
inflammation. We hypothesize that menopausal WLWH will develop genital tract aging earlier than HIV-
menopausal women and that the magnitude of difference in aging biomarkers including increased dysbiosis,
less bacterial Ig coating, and increased mucosal inflammation will be greater when comparing younger (45-55
years) and older (56-70 years) menopausal WLWH to younger and older HIV- menopausal women. Estrogen
has been shown to improve atrophy symptoms and the vaginal microbiome in HIV- postmenopausal women
but has not been studied in menopausal WLWH. We will therefore conduct a pilot randomized clinical trial in 50
HIV+ menopausal women with symptomatic vaginal atrophy to test the hypothesis that vaginal estradiol
treatment will result in a more optimal Ig coated lactobacillus-dominant vaginal microbiome, reduction in
mucosal inflammation, and improvement in symptoms. I will develop expertise in the conduct of clinical
trials/studies in aging populations and cutting-edge laboratory techniques (IgSeq, RNAseq). I will also pursue
training in analysis of microbiome data including metagenomics. This award will allow me to become an
independently funded clinician scientist studying the impact of HIV on mucosal immunity and aging in the FGT.

Public health relevance
HIV may be associated with premature aging in the female genital tract including alterations in the vaginal microbiome and mucosal inflammation, which may increase risk for vaginal atrophy, UTIs and other genital tract infections. This study will determine if HIV is associated with accelerated genital tract aging including earlier and more pronounced changes in the vaginal microbiome and mucosal inflammation in menopausal women living with HIV (WLWH) compared to HIV uninfected menopausal women. We will then test whether vaginal estradiol will improve symptoms and the vaginal microbiome and reduce mucosal inflammation in menopausal WLWH with vaginal atrophy, thereby improving vaginal health and healthspan.